Developmental cell census of human and non-human primate brain

ABSTRACT
The human brain is a highly complex biological tissue organized into hundreds of regions composed of a myriad
of cell types with distinct molecular, morphological, and physiological properties. These cells and their associated
circuits underlie our mental abilities and, when dysfunctional, lead to neurological and psychiatric disorders.
Consequently, developing an atlas of these cell types and how they differ from one another is essential for
understanding the biological processes underlying human brain development and function. In addition, because
both the general cytoarchitecture of the brain and its constituent cells are generally conserved across primates,
knowledge of how these cell types differ between species is also essential for understanding uniquely human
aspects of cognition and behavior. We therefore propose to use single cell transcriptomics to rigorously define
cell types and states in ten brain regions involved in higher cognition and behavior and across five key
developmental timepoints of human, chimpanzee (one of our closest extant relatives), rhesus macaque (the
most commonly studied Old World non-human primate), and common marmoset (an emerging New World non-
human primate model system). By generating, analyzing, and integrating these data with existing unpublished
datasets, we propose to develop a human and non-human primate cell atlas and identify shared and divergent
molecular and cellular features across species, regions, and ages. Furthermore, we will validate key aspects of
this atlas, including molecular signatures, and create a data visualization and dissemination portal.

Public health relevance
NARRATIVE We propose to carry out the systematic generation and subsequent integrative analysis of transcriptional profiles of single cells from various anatomical regions of the human and non-human primate brain. This work is essential for better understanding the organization and function of the human brain, and how the underpinnings of the unique social, cognitive, and behavioral repertoire of our species are distinct from those of other primate species.